Synergistically Target Mitochondria for Heart Failure Treatment

SUMMARY/ABSTRACT
Heart failure (HF) is a leading cause of death worldwide. Although the pathophysiology of HF is complex and
remains incompletely understood, defects in mitochondrial function have been implicated in the progression and
outcomes of HF, and emerged as an important target for HF therapy. One well-known contributing factor to
adverse cardiac remodeling in the failing hearts is excess mitochondrial-derived reactive oxygen species
(mtROS). Accordingly, a variety of antioxidant-based therapies have been developed for HF treatment over the
last decades. However, despite promising outcomes in preclinical studies, translation of these therapies to the
clinic has not succeeded to date, suggesting that alternative or complementary mitochondrial therapeutic targets
are needed. In addition to excess mtROS, profound loss of mitochondrial membrane potential (m) is another
key hallmark of HF. In the cardiomyocyte (CM), m disruption affects not only energy production, but also a
variety of signaling pathways crucial for cell function and survival, such as redox balance, calcium homeostasis
and mitochondrial quality control. We hypothesize that synergistically targeting mitochondria, i.e., concurrently
preserving mitochondrial m and scavenging excess mtROS, is a viable therapeutic strategy for HF treatment.
However, assessing the therapeutic potential of m preservation is challenging, due to a lack of tools for
dynamic and specific control of CM m in live animals. To overcome this technical barrier, we developed an
innovative mitochondrial-targeted luminoptogenetic (named mLumOpto) technology by integrating luciferase-
luciferin-emitted endogenous bioluminescence with the mitochondrial optogenetics we recently published. Our
preliminary data indicate that mLumOpto can induce dynamic CM m control in the absence of external light
illumination. The primary goal of this project is to employ this advanced mLumOpto technology to manipulate
CM m in vivo to evaluate the efficacy of CM m preservation alone, or in synergism with a mtROS scavenger
(i.e., mitochondrial-specific antioxidant), in HF treatment in preclinical mouse models. The translational potential
of the proposed synergistic mitochondrial-targeted HF therapy will also be assessed in human-like large animals
(i.e., pigs). Three Specific Aims are proposed to accomplish our objectives. Aim 1 will determine the role of
sustained CM m depolarization in pathological cardiac remodeling and HF development in mice, and dissect
the underlying molecular mechanisms. Aim 2 will evaluate the efficacy of synergistic m preservation and
mtROS scavenging in improving adverse cardiac remodeling and contractile dysfunction in two well-established
mouse HF models (i.e., pressure overload and myocardial ischemia-reperfusion). Aim 3 will assess the
translational potential of mLumOpto-mediated HF therapy in pigs. Successful completion of this project will lead
to not only an innovative technology capable of specifically and dynamically manipulating CM mitochondria in
vivo, but also a novel translational mitochondrial-targeted therapy for HF treatment.

Public health relevance
PROJECT NARRATIVE While defects in mitochondrial function are implicated in the pathogenesis of heart failure (HF), translation of mitochondrial-targeted HF therapy to the clinic has not succeeded to date. This project will employ an innovative luminoptogenetic technology to evaluate the therapeutic efficacy of preserving cardiomyocyte mitochondrial function in improving cardiac remodeling and contractile dysfunction in the failing hearts. The findings will not only advance our understanding of the mechanisms connecting mitochondrial dysfunction and pathogenesis of HF, but also lead to the development of a novel synergistic mitochondrial-targeted therapy for HF treatment.